Understanding genomic stability betweengenerations by assessing mutational burdens in single sperms

PROJECT SUMMARY/ABSTRACT
Mutations during embryonic development, aging, cellular metabolism, and environmental exposure are
permanently recorded in the genomes of each cell and its daughters. Depending upon whether the mutations
can be detected in regular next-generation sequencing, they are recognized as clonal or non-clonal in nature
and present different features. Elucidating the patterns of these mutations and their potential to transmit to
offspring is key to understanding congenital de novo mutation (DNM) disorders and genetic variability across
human generations. As parents age, the number of DNMs in their germ cells increases, and with this, an
increased risk of DNMs and the disease they cause in offspring. Although age-related DNM risks have been
reported in large populations, our understanding of how paternal-specific clonal and non-clonal mosaicism
contribute to offspring and how natural selection shapes the mutation pattern is still limited. During my previous
graduate and postdoctoral research, I established the concept that a considerable portion of DNMs in children
with neurological and psychiatric disorders arise from clonal mosaic mutations in the sperm (Yang, et al. Cell
2021). I developed experimental and computational pipelines to accurately detect clonal mosaic mutations in
bulk samples with deep whole-genome sequencing (Yang, et al. Nature Biotechnology, in press; Breuss, Yang,
co-firsts, et al. Nature 2022). In this K99/R00 application, I aim to unravel the feature of the non-clonal gonadal
mutation burden at the single-cell level, employing multidisciplinary approaches spanning the mentored [K99]
and independent [R00] award phases. I will compare the genomic sequences from 700 single human sperm
from bulk sperm sequences in 35 healthy young men, analyze the genomic positions where the non-clonal
mutations tend to reside compared to the clonal ones, and study the impact of those mutations (Aim 1). I will
develop new computational software to accurately detect mosaic mutations from single cells not only from
haploid and diploid genomes, and develop experimental approaches to accurately validate the somatic mutations
from single-cell amplified DNA (Aim 2). Finally, I will measure the single-cell DNA mutation rate and mutation
patterns using 2300 single sperm from an additional 45 young versus 75 aged donors for clues on age-related
mutational mechanisms and how they will impact the genome stability in the next generation before and after
natural selection (Aim 3). Overall, the results from this proposal will help us to understand the non-clonal mosaic
mutational burden, mutation distributions, as well as mutational functions in human sperm, and the age-related
genetic impacts on the genome stability of the next generation. My career goal is to lead an independent research
group focusing on somatic mutations in the human genome, their causes, and predicting their consequences on
child health. During the K99 phase, I will continue to receive subject recruitment, reproductive science,
experimental, computational, and career development training from my postdoctoral advisor Dr. Gleeson, co-
mentors Dr. Wilkinson and Sebat, as well as external mentors at UC San Diego and other institutes. The rigorous
mentored support will greatly my knowledge in human subject handling and reproductive science, as well as
getting me prepared for job applications. The results obtained in the K99 phase will facilitate my transition to an
independent investigator in the R00 phase and lay the foundation for my future career.

Public health relevance
PROJECT NARRATIVE Mosaic mutation in sperm is an important source of new mutations and underlies sporadic genetic risk for congenital diseases in offspring, this proposal aims to uncover how mutations in single sperm look like, what impacts they have, and how they accumulate with age. I will obtain training in the related fields of reproductive medicine and human subjects, as well as develop both computational and experimental technologies to study the genomes of individual single sperm and generalize them to other studies. The proposed project will not only advance novel technologies for the analysis of single sperm genomes and detect mosaic variants but will also advance a fundamental understanding of paternal non-clonal sperm mosaicism and predict its significant contributions to child health.